Dissecting Behavioral and Neural Mechanisms of Hand Dexterity after Stroke for Effective Rehabilitation

PROJECT SUMMARY
Following a stroke, hand dexterity does not recover fully for most patients, significantly reducing quality of life.
Optimal and effective assessment and therapies for achieving hand dexterity are currently lacking due, in part,
to limited scientific knowledge of human hand dexterity in health and disease. Hand dexterity hinges on
multiple essential behavioral components embedded in a highly interactive neural circuit. How the behavioral
components interact and how they are supported by descending neural pathways are still unclear. The long-
term goal of this research is to build a predictive model and identify key behavioral and neural principles for
designing targeted therapies to facilitate the reacquisition of hand dexterity to improve quality of life. The
current objective of this project is to investigate behavioral and neural mechanisms of hand dexterity and its
impairment and recovery after stroke. The central hypothesis is that three essential components of hand
function, finger individuation, precision grip, and power grip, largely rely on three distinct control variables,
flexibility, coordination, and strength, and separable descending pathways: direct- and indirect-corticospinal
tract (CST), and reticulospinal tract (RST). The rationale for this project is that directly comparing different
components of dexterity using kinematics/kinetics at the same levels of granularity, combined with the most
advanced measures of descending neural pathway structure and function holds promise in a new model of
hand dexterity. Two specific aims are proposed to test the central hypothesis: 1) characterize effect of stroke
on individuation, precision grip, and power grip; and 2) determine if stroke-related disruption in the structure
and function of three descending neural pathways are associated with three behavioral components. Under
Aim 1, chronic stroke patients and healthy controls’ Individuation and Precision Grip will be directly compared
using isometric forces recorded in high resolution at all ten fingertips in 3D, and their interaction with Power
Grip will be examined. Under Aim 2, high-resolution tractography using diffusion-weighted MRI will be obtained
to assess structural integrity of the three descending pathways. Transcranial magnetic stimulation (TMS)
paired with peripheral nerve stimulation will be used to assess functional involvement of the three pathways
using short-, long-, and extra-long interval modulation of Hoffmann-reflex. Under Aim3, a model will be built to
map severity of impairment in behavioral measures to neurophysiological markers derived from Aim 1&2 to test
the hypothesis that stroke survivors’ direct-, indirect-CST and RST measures will be predictive of individuation,
precision grip, and power grip behaviors, respectively. The proposal is innovative because it reconceptualizes
dexterity by, for the first time, directly assessing essential components of dexterity behaviors and descending
pathways with cutting-edge techniques and build a neural model from these findings. It is significant because
findings from this project will guide the creation of sensitive clinical assessments and redefine therapeutic
interventions for optimal hand rehabilitation after stroke to enhance patients’ quality of life.

Public health relevance
PROJECT NARRATIVE The proposed project is relevant to public health because it aims to reconceptualize dexterity and identify critical factors in rehabilitation of hand dexterity among stroke survivors by characterizing essential behavioral components and their neuroanatomical substrates, from which a neural mechanistic concept can be built. Upon successful completion, a new model of hand dexterity and a sound rationale for developing effective therapeutic interventions will emerge, which will facilitate reacquisition of dexterity and optimization of hand function recovery. Thus, the proposed research is relevant to the part of the NIH’s mission that pertains to the application of the scientific and clinical knowledge gained from this project to enhance health and reduce disability.